Hot Flashes and Neurovascular Function in Women

PROJECT SUMMARY/ABSTRACT
Vasomotor symptoms (hot flashes) associated with menopause consist of rapid and intense sweating,
peripheral vasodilation, and an exaggerated feeling of internal heat. Over 70% of women experience hot
flashes at some point during menopause, which significantly impacts day to day life. Furthermore, hot flash
frequency is related to increased risk of hypertension, cardiovascular disease (CVD), sleep, and mood
disorders--even when controlling for traditional cardiovascular disease risk factors (obesity, hypertension,
lipids, etc.). As such, the overall goal of this application is to determine autonomic neurovascular function in
midlife women with and without vasomotor symptoms (hot flashes). For the purposes of this application we will
define neurovascular function as a concept that encompasses sympathetic outflow, the responses of blood
vessels to neurotransmitters released by the sympathetic nerves and the intrinsic properties of the vascular
endothelium and smooth muscle. It is thus related to the regulation of tissue blood flow. In this context,
neurovascular function is critically important to women’s health and aging. Aim 1 will compare microvascular
function in women with objectively assessed low and high frequency hot flashes. Aim 2 will determine
autonomic function and reactivity in women with objectively assessed low and high frequency hot flashes.
Finally, Aim 3 will characterize cerebrovascular function in women with objectively assessed low and high
frequency hot flashes. Importantly, this work will provide the first comprehensive and mechanistic evaluation of
autonomic and neurovascular function in midlife women including those undergoing menopause.
Understanding how the neurovascular physiology of women relates to hot flashes will inform hypertension and
cardiovascular disease (CVD) treatment and prevention options, as the presence of hot flashes are a CVD risk
factor beyond traditional CVD risk factors and as such, is likely to be an important determinant for a woman’s
health. Thus, the Applicant’s long-term goal is to develop interventions to reduce the incidence of
cardiovascular disease in women with hot flashes. The proposed studies will build on the Applicant’s previous
training and the mentorship team, formal course work on running clinical trials, and technical training plan will
provide opportunities to gain additional knowledge in a new area and learn new experimental techniques and
approaches. Finally, this work will generate an investigative niche that will complement the Applicant’s
intellectual and technical skills that will facilitate the launch of her independent career.

Public health relevance
PROJECT NARRATIVE Women who experience hot flashes are at greater risk for hypertension and other cardiovascular disease. Neurovascular control mechanisms are likely to play an important role in this relationship. As such, these studies are designed to provide a major step forward in understanding the link between hot flashes and neurovascular dysfunction and, by extension, cardiovascular disease in women.